Administrative Supplement for Peer-Delivered and Technology-Assisted Integrated Illness Management and Recovery

PROJECT SUMMARY
Adults with serious mental illness (SMI) are disproportionately affected by medical comorbidity, earlier onset of
disease, and 10 to 25 years reduced life expectancy compared to the general population. These high rates of
morbidity and early mortality are associated with inadequately managed medical and psychiatric illnesses. Our
systematic review found nine effective self-management interventions that address medical and psychiatric
illnesses in adults with SMI. However, there has been limited adoption of these interventions due to both
provider and patient-based factors. Provider-based barriers consist of the lack of an adequate workforce with
the capacity, time, and knowledge of effective approaches to self-management support for adults with SMI and
chronic health conditions. Patient-based barriers associated with limited participation in self-management
programs include lack of access, engagement, and ongoing community-based support for persons with SMI.
Peer support specialists have the potential to address these barriers as they comprise one of the fastest
growing sectors of the mental health workforce, have “lived experience” in self-management practices, and
offer access to support in the community. However, challenges need to be resolved for peers to be effective
providers of evidence-based interventions. For example, peers are frequently trained to provide “peer support”
described as “giving and receiving help founded on key principles of respect, shared responsibility, and mutual
agreement of what is helpful”. Peer support has been associated with increased sense of control, ability to
make changes, and decreased psychiatric symptoms. Despite benefits, peer support does not adhere to
evidence-based practices for psychiatric and medical self-management and does not follow protocols that
ensure fidelity and systematically monitor outcomes. We hypothesize that mobile technology has the potential
to overcome these limitations of peer support by providing real-time guidance in fidelity adherent delivery of a
peer-delivered, technology-assisted evidence-based self-management intervention (PDTA-IIMR). The purpose
of this K01 award is to build the necessary expertise to pursue a career developing and testing novel
approaches to peer-delivered evidence-based self-management interventions. Training will include:
development of peer-delivered interventions; development and design of mobile health-supported
interventions; and intervention clinical trials research. Concurrently, I propose to refine the intervention protocol
with input from peers and patients. Then, I will conduct a pilot study evaluating the feasibility and potential
effectiveness of PDTA-IIMR compared to routine peer support for N=6 peers and N=40 adults with SMI and
chronic health conditions. Outcomes include feasibility, medical and psychiatric self-management skills, and
functional ability. We will explore mortality risk factors and examine self-efficacy and social support as
mechanisms on outcomes.

Public health relevance
PROJECT NARRATIVE This training and research plan are designed to assist the applicant in acquiring the skills to become to an independent investigator in developing and testing novel approaches to peer-delivered evidence-based self- management interventions for adults with serious mental illness (SMI). Mentored activities and training will include: development of peer-delivered interventions; development and design of mobile health-supported interventions; and intervention clinical trials research. Concurrently, I will conduct a program of research aimed at developing and evaluating a peer-delivered, technology-assisted medical and psychiatric self-management intervention (PDTA-IIMR), including (1) a qualitative study designed to inform the development of PDTA-IIMR by identifying barriers and facilitators of (a) peer specialists delivering evidence-based medical and psychiatric self-management support; and of (b) patients engaging in medical and psychiatric self-management interventions through semi-structured interviews with peers (N=20) and patients with SMI (N=20); and (2) a randomized pilot study evaluating the feasibility and potential effectiveness of a PDTA-IIMR compared to routine peer support for N=6 peers and N=40 adults with SMI and chronic health conditions. .